Design of Phosphoranyl Radical α-scisson Reactions Enabled by Photoredox Catalysis and 1,5-Hydrogen

New methodologies to construct C–C, C–N, C–O, and other C–heteroatom bonds are crucial for the
continued development of new pharmaceutical candidates. Photoredox catalysis has emerged as a powerful
field of organic chemistry for this purpose; however, while many organic functional groups are within the oxidation
and reduction potentials of the growing library of photocatalysts, several important groups remain inaccessible
either due to their redox potentials or chemoselectivity challenges. In-situ phosphoranyl radical generation by
photoredox catalysis has emerged as a promising alternative to activate such desirable functional groups. There
are two major scission pathways from the phosphoranyl radical: 𝛼- and 𝛽-scisson. The reversibility of
phosphoranyl radical 𝛼-scission has precluded its application toward generation of highly desirable oxygen-
centered radicals from alcohols.
This proposal details the application of phosphoranyl radical 𝛼-scisson on sulfonamide and alcohol
substrates able to undergo a rapid intramolecular 1,5-hydrogen atom transfer (HAT) step after the 𝛼-scisson
event. In the first aim, the catalytic phosphine/photoredox system will be evaluated with secondary sulfonamide
substrates, which were unable to engage in productive reactivity in the previous hydroamination work. Distal
functionalization, pyrrolidine synthesis, and distal multifunctionalizations will be accomplished under similar sets
of reaction conditions. The second aim focuses on engaging a more challenging class of substrates in
phosphoranyl radical 𝛼-scisson: alcohols. Through the use of conformationally-strained phosphetanes and by
again coupling 𝛼-scisson to 1,5-HAT, we will activate aliphatic alcohols through phosphine/photoredox catalysis
in a net-oxidative reaction to form substituted tetrahydrofurans. This catalyst design will then be applied to the
first catalytic in phosphine 𝛽-scisson of alcohols for deoxygenation, a valuable medicinal reaction that has
remained inaccessible through phosphoranyl radical scission because it results in P(V). Through redox-cycling
the strained phosphetane, complex scaffolds such as steroids and carbohydrates can be deoxygenated under
catalytic conditions. In both aims, DFT calculations will be utilized to calculate the potential energy surfaces of
the key scission events of the phosphoranyl radical, as well as the 1,5-HAT step and possible back-electron
transfer of the heteroatom radical with the photocatalyst. In aim 2, a free-energy relationship between the
computed conformational strain of synthesized phosphetanes and the scission events will be established.
Development of these strategies provide new applications of photoredox-enabled phosphoranyl radical 𝛼-
scisson, allowing access to valuable, medicinally-relevant scaffolds including complex sulfonamides,
pyrrolidines, tetrahydrofurans, and deuterated compounds. By understanding the factors that influence the
energetics of the key mechanistic steps, this work will enable future reaction development in this area.

Public health relevance
New methodologies to construct C–N and C–O are crucial for the continued development of new pharmaceutical candidates, representing the lion’s share of medicinal chemistry’s bond-forming reactions. Phosphoranyl radical scission enabled by photoredox catalysis possesses the ability to develop new C–N and C–O bond-forming methodologies to make valuable scaffolds such as pyrrolidines and tetrahydrofurans from sulfonamides and alcohols, as well as late-stage deuterations of complex scaffolds such as steroids and carbohydrates. Taken together, the proposed work could facilitate the development of new medicines, and completion of this work will result in a better understanding of the downstream chemical events which affect the selectivity of phosphoranyl radical scission, which will in turn result in the development of novel transformations in the future.